Nucleus accumbens processing of reward-predictive cues

Project Summary
Salient sensory events can elevate the arousal level, increasing the subject's readiness to engage motor,
cognitive and attentional resources. For example, arousal is increased when a sleeping person is shaken awake,
or when a quiescent rat is transferred to a new cage or otherwise handled. Recent evidence shows that the
dopamine projection from the midbrain ventral tegmental area to the nucleus accumbens (NAc) core serves to
elevate arousal in response to such events, and that this effect likely involves both D1 and D2 dopamine receptor-
expressing NAc neurons. Yet, this role for mesolimbic circuitry in arousal has not been reconciled with the large
literature that interprets the behavioral effects of NAc dopamine manipulations as the result of altered motivation
or reward. To investigate how arousal might contribute to the reward-seeking effects of dopamine, we first
established a behavioral paradigm in which rats' performance of a cued operant task declines over time due to
gradually decreasing arousal. We find that simply handling the animal for a few seconds dramatically restores
high levels of performance for many minutes. Handling also increases dopamine levels in the NAc and the firing
response of NAc neurons to reward-predictive cues, which are known to be dopamine-dependent and causal to
the cued reward-seeking behavioral response. These results suggest that the dopamine increase caused by
arousing events facilitates reward seeking. This is one of the major hypotheses tested in this proposal.
This hypothesis suggests an even more provocative idea: that NAc dopamine promotes reward seeking by
increasing arousal. If that were the case, then dopamine should act via the same local circuit mechanism within
the NAc to increase both arousal and reward seeking. Previous studies point towards (but do not conclusively
demonstrate) a specific circuit mechanism common to both processes: D1 neurons are the “effector” neurons
whose firing drives both arousal and reward seeking, whereas D2 neurons strongly inhibit D1 neurons. Dopamine
promotes arousal and reward seeking primarily by acting at the D2 receptor to reduce the inhibitory drive from
D2 neurons onto D1 neurons, and only secondarily (if at all) by directly increasing the excitability of D1 neurons
by acting at the D1 receptor. This circuit model receives a great deal of indirect support from disparate published
experiments, as well as our pilot experiments, that have tested individual components of the model in isolation
from the others. In this proposal, we aim to test the model cohesively and thoroughly, and in doing so, to establish
that dopamine increases both arousal and reward seeking by the same local NAc circuit mechanism. Doing so
will reframe current thinking regarding the behavioral role of mesolimbic dopamine in two ways; first, by
establishing the causal contribution of D2 neurons' inhibition of D1 neurons (and the relief of this inhibition by
dopamine) to both arousal and reward seeking; and second, by showing that dopamine facilitates arousal and
reward seeking via the same local circuit mechanism – which will introduce the field to the hypothesis that
dopamine's well-known ability to promote reward seeking could be due in part to increased arousal.

Public health relevance
Health Relevance All drugs of abuse cause levels of the neurotransmitter dopamine to be elevated in the nucleus accumbens. This effect is considered critical to the addictive and psychomotor activating properties of abused drugs, as well as to the arousing effects of psychostimulants, but the specific neural mechanisms at play remain enigmatic in part because the natural functions of accumbens dopamine are poorly understood. By determining how dopamine alters the activity of accumbens neurons to promote both arousal and reward-seeking behavior, we will open a new path towards understanding how the elevated dopamine caused by drugs leads to the behavioral consequences of taking these drugs, which may ultimately lead to novel therapeutics to treat addiction.